Can neural network instability in schizophrenia be improved with a very low carbohydrate ketogenic diet?

PROJECT SUMMARY/ABSTRACT
This diversity supplement will significantly enhance the research potential of Ms. Zanib Naeem
and make her competitive for top-tier PhD programs. Ms. Naeem will be involved in a team
project that focuses on the benefits of a ketogenic diet in overweight people with schizophrenia.
She will become familiar with an array of tools we use in our studies of the pathophysiology of
schizophrenia: structural and functional MRI, neuropsychology, and clinical interviews. She will
also participate in the Post-Bac Program for Equity and Learning (PROPEL) curriculum
activities, on which the PI (Dr. Ford) serves as a mentor. Through the PROPEL program, Ms.
Naeem will both participate in biomedical seminars and have access to career development
opportunities, such as grant writing workshops and mock interviews.

Public health relevance
NARRATIVE In this supplement application, the goal is for Ms. Naeem to work with our team to collect and analyze neurobiological data, participate in interviewing the people with schizophrenia, and augment the project with neuroanatomical data that she will be trained to extract.